Core A: Administrative Core

Abstract/Summary – Administrative Core
The Administrative Core will be responsible for the overall leadership and scientific oversight of the Michigan
Metabolic Phenotyping of live Models of Obesity and Diabetes (Mi-MPMOD) Center. The Core will provide
administrative assistance to the Animal Care and Germ-Free Core and the Metabolic, Physiological and
Behavioral (MPB) Phenotyping Core and ensure that their services are delivered efficiently and to the highest
possible standards. The leadership team has extensive administrative experience and is centrally located in
the North Campus Research Complex at the Elizabeth W. Caswell Diabetes Institute (CDI), adjacent to
administrative cores of the Michigan Diabetes Research Center (MDRC), the Michigan Nutrition and Obesity
Research Center (MNORC) and the CDI. This clustering of related Administrative Cores facilitates an efficient
use of space and equipment and leverages the collective experience of all centers’ administrators assuring the
transfer of best practices among them. The administrative core will: a) Coordinate the receipt of animals and
assignments for the appropriate phenotyping services; b) monitor studies progress until completion of data
analysis and submission of final reports to the requesting investigator(s); c) ensure secure processing and
signing of all necessary conditions of use statements, contracts, service fees, and data records as well as the
subsequent data submission to the MPMOD Consortium and Coordinating Unit (CU) database; d) manage
budgetary and workflow records, oversee cost recovery, program income and adjustment of service charges;
e) re-budget Center funds based on the cores service activity and scientific needs; f) promote the availability of
MPMOD resources to local investigators, regional partners, and nationwide research institutions, including
academic and for-profit biotechnology and pharma companies; g) develop communication strategies to
specifically target underrepresented PIs and small laboratories or institutions that have not received significant
federal research funding through advertisement, seminars, and direct contact with the academic departments;
h) facilitate the development of new research technology and training resources for the Center’s MPB
Phenotyping Core; and i) meet regularly with the Advisory committees and oversee the preparation and
submission of annual progress report to NIDDK. The Administrative Core will work closely with the Centers’
Consortium and the national CU by actively participating in the solicitation and review of applications for the
MPMOD Consortium’s funding programs. It will also work in synergy with the Consortium and CU to minimize
overlap of services and establish, standardize, document, and distribute phenotyping protocols and quality
control procedures to laboratories nationwide.